Neural Control of Breathing

PROJECT SUMMARY/ ABSTRACT
Breathing is a remarkable behavior fundamental to life that mediates gas exchange to support
metabolism and regulate pH. A reliable, non-stop, robust rhythmic pattern of respiratory muscle
activity is essential for breathing in mammals. Failure to maintain a normal breathing pattern in
humans suffering from sleep apnea, apnea of prematurity, congenital central hypoventilation
syndrome, hyperventilation syndrome, Rett syndrome, and perhaps Sudden Infant Death
Syndrome, leads to serious adverse health consequences, even death. Various neuro-
degenerative diseases, such as Parkinson's disease, multiple systems atrophy, and
amyotrophic lateral sclerosis, are associated with sleep disordered breathing that appear to
result from the loss of neurons in brain areas controlling breathing. If breathing is to be
understood in normal and in pathological conditions, the mechanisms for breathing central
pattern generation must be revealed. We focus on two brainstem sites essential for generation
of the normal breathing pattern, the preBötzinger Complex and the retrotrapezoid
nucleus/parafacial respiratory group. We propose a broad series of experiments both in vivo
and in vitro in rodents using state-of-the-art techniques to significantly advance our under-
standing of respiratory rhythm and pattern generation to provide an extraordinary window into
the mechanisms underlying the neural control of breathing. Such advancements will be
foundational for development of highly novel therapies for treating human diseases of breathing.

Public health relevance
PROJECT NARRATIVE In humans, continuous breathing from birth is essential to life and requires that the nervous system generate a reliable and robust rhythm that drives inspiratory and expiratory muscles. The proposed studies will significantly advance our understanding of the neural mechanisms generating breathing rhythm and pattern in both health and diseases of respiratory failure. We will determine one or more critical subpopulations of neurons that can be targeted for treatment of respiratory failure during opioid overdose, sudden unexpected death in epilepsy, and central sleep apnea.